Cocaine-Mediated Modulation of Dopamine Transmission and Its Effects on Peripheral Immunity

Project Summary
Midbrain expressing dopamine transporter (DAT), located in the ventral tegmental area (VTA) and substantia
nigra pars compacta (SNpc), are involved in psychostimulant use disorders, psychiatric diseases, movement
disorders, and HIV-associated neurocognitive disorder. Cocaine, a highly addictive psychostimulant, blocks
DAT-mediated dopamine (DA) uptake, increasing extracellular DA levels in the CNS. Key to this proposal,
activation or inhibition of DA neurons impacts peripheral immunity. For example, I have shown that peripheral
immunity is dysregulated when DA neurons are lesioned, suggesting that midbrain DA can influence peripheral
immunity, but the midbrain-to-peripheral circuitry is poorly understood. My pilot data suggest that midbrain DA
neurons send projections to the dorsal vagal complex (DVC) and make synapses within the DVC. Neurons in
the DVC express D1-like and D2-like dopamine receptors and change their activity in response to dopamine.
The DVC projects to multiple organs, including the spleen via the celiac ganglion. My pilot data support the
connection between midbrain-DVC-spleen, and that chemogenetic stimulation of midbrain DA neurons alters
splenic immunity. I have also shown that immune cells express DAT, where in immune cells DAT activation is
immune suppressive, highlighting distinct roles for DAT activity on peripheral immune cells versus DAT activity
in the brain. Mice with global DAT deletion (DAT KO) exhibit heightened peripheral inflammatory responses to
immune challenges, supporting an immune suppressive role for DAT in peripheral immunity. To study CNS DAT
activity on peripheral immune cells independent of DAT's effects on peripheral immune cells, I generated mice
chimeras with selective DAT deletion in the peripheral immune system (while keeping CNS DAT intact).
Preliminary experiment in these chimeric mice shows immune cells DAT deletion causes distinct immunological
changes compared to global DAT KO. My pilot data support the hypothesis that midbrain DA neuron activation
affects peripheral immune responses via DA release in the DVC, regulating a midbrain-DVC-spleen circuit
independent of immune cell DAT activity. In Aim 1, I will use viral tracing approaches to investigate whether
midbrain DA neurons project to and make synapses within the DVC, whether these projections extend to the
spleen in a multi-synaptic mechanism, and whether activation or inhibition of these neurons modulate splenic
immunity. In Aim 2, I will investigate whether systemic cocaine versus locally applied cocaine in the CNS
differentially affect splenic immunity. In Aim 3, I will test the hypothesis that DAT on peripheral immune cells
modulates their immune response to immune stimulation.
The results will provide novel insights into how DAT-
expressing neurons influence the immune system and the independent role of DAT in immune cells, providing
strong conceptual and methodological training under Drs. Khoshbouei and Okun, and under a mentoring team
comprised of established professors, who are experts in the proposed approaches and are accomplished
mentors, helping me to complete the proposed research and achieve career development goals of this proposal.

Public health relevance
Project Narrative This proposal investigates the anatomical and functional connectivity between the midbrain and peripheral immune system in the context of cocaine use disorder. While dopamine signaling has been well studied in substance use disorder and neurodegenerative diseases, its impact on peripheral systems and brain-to- periphery remains underexplored. By investigating how dopamine influences peripheral immunity, and the neurocircuitry involved, this research aims to uncover novel therapeutic targets to address both central nervous system and systemic complications associated with cocaine use disorders in addition to providing the applicant (Dr. Gopinath) to have the tools, technical skill, and training necessary to launch a successful independent research career.